Conserved regulation of proteostasis by post-translational protein AMPylation

PROJECT SUMMARY/ABSTRACT
The primary goal of this Administrative Supplement application is to develop a fundamental understanding of
the Alzheimer’s disease-associated changes in brain-wide protein AMPylation. Protein AMPylation is conferred
by dedicated AMPylases, which exist as a single copy in most metazoans. These enzymes are increasingly
recognized to control proteostasis, modulating how and when amyloidogenic proteins, such as β-amyloid
peptide (Aβ), α-synuclein (α-Syn) and polyglutamine repeat proteins, aggregate. The goals of the parent award
(R35 MIRA) are to 1) dissect the mechanistic and physiological impact of FIC-1/FICD-mediated protein
AMPylation on proteostasis, and 2) elucidate the mechanistic basis of protein AMPylation in the cytoplasm and
nucleus. Our research program is utilizing four complementary model systems: the nematode C. elegans,
purified proteins for in vitro biochemistry, human cell lines and in vivo mouse models, each offering its unique
set of advantages to examine the consequences of aberrant protein AMPylation. In preliminary work expanding
from the parent award, we determined that the conserved AMPylase, FICD, accumulates in the nucleus of
Alzheimer’s disease patient neurons, whereas the enzyme resides perinuclear in neurons of neurologically
unaffected brain tissue. Recent advances in tool and assay development now make it feasible to assess
protein AMPylation in human brain tissue by immunofluorescence staining and immunoblotting approaches.
This proposed supplement will allow us to identify changes in protein AMPylation in specific brain regions and
cell types with the goal of defining a pathogenic role for these changes during the initiation and progression of
Alzheimer’s disease and age-related dementias. This project will deliver a first-in-kind map of protein
AMPylation in the human brain and establish novel links between protein AMPylation and Alzheimer’s disease.
We will annotate, curate, and rapidly disseminate the data to the broad scientific community prior to publication
to maximize the utility of these data for meta-analysis and systems biology research.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Alzheimer’s disease and related disorders are hallmarked by impaired proteostasis, which facilitates pathologic protein aggregation and causes neuron degeneration. A more detailed understanding of the dysregulation of proteostasis associated with the pathogenesis of Alzheimer’s disease will enable the discovery of new effective and durable therapies. Here, we will employ a strategy that uses novel tools to reliably detect protein AMPylation with increased sensitivity to deliver a fundamental understanding of how changes in FICD- mediated protein AMPylation affect proteostasis in the brain of Alzheimer’s disease patients and predispose neurologically unaffected controls to a neurologically degenerative state; this is a prerequisite to therapeutically target this enzyme to improve health and fitness of the aging human brain.